Testing the Effectiveness of NAFLD Clinical Care Pathway in VA Primary Care

Background: In the United States, non-alcoholic fatty liver disease (NAFLD) affects 25-30% of adults and has
become a leading cause of chronic liver disease including cirrhosis and liver cancer. The burden of NAFLD and
its complications among patients in the Department of Veterans Affairs (VA) is increasing. Most complications
occur among patients with advanced hepatic fibrosis. Treatment (e.g., weight loss) improves patients’ outcomes.
Significance: Our data indicate that most VA patients with NAFLD are undiagnosed and untreated. There is an
urgent need to address this major gap in care. Most people with NAFLD are seen in primary care settings. The
NAFLD Clinical Care Pathway (NCCP) is a multistep, algorithmic process that entails identification of patients at
risk through an e-trigger (Step 1), targeted history and lab testing (Step 2), noninvasive testing for hepatic fibrosis
using FIB-4 (Step 3), elective additional fibrosis testing with Fibroscan for those with indeterminate FIB-4 (Step
4), and subsequent recommended management. The NCCP has face and content validity based on consensus
of multiple stakeholders including VA clinicians, and high efficacy in our preliminary data. We propose to adapt
the multicomponent NCCP intervention for use in VA primary care and prospectively test its effectiveness for
identification and severity stratification of patients with NAFLD. Our approach is consistent with VA strategic
priorities to implement a more “Veteran-centered” approach that improves access to care.
Innovation & Impact: This is the first study to examine the effectiveness of any NAFLD clinical care pathway in
a VA primary care practice. The design is a cluster-randomized controlled trial with randomization at the level of
Patient Aligned Care Teams (PACTs) in primary care, and a state-of-the-art technique to diagnose NAFLD and
stage the severity of hepatic fibrosis. Our formative and summative evaluation will provide key information about
the feasibility, acceptability and determinants of implementation. The NCCP intervention is a paradigm shift in
NAFLD care from haphazard and sporadic care into a systematic, equitable, and evidence-based approach.
Specific Aims: Aim 1. Conduct a formative evaluation to assess feasibility and acceptability of the NCCP among
patients and providers; adapt the NCCP for prospective testing based on feedback. Aim 2. Examine the
effectiveness of the NCCP intervention compared to usual care in improving NAFLD care processes and patient
outcomes. Aim 3. Conduct a summative evaluation to identify patient and provider characteristics associated
with effectiveness of NCCP and to assess future implementation. Our hypothesis is that NCCP when adapted to
Patient Aligned Care Teams (PACTs) in VA primary care considerably increases the identification of patients
with NAFLD and those with high-risk NAFLD, and results in an increase in guideline-concordant management.
Methodology: The study will be conducted in primary care settings in a single large VA Medical Center. We will
conduct patient interviews and focus groups with PACTs to inform adaption of the NCCP. We will then conduct
a cluster-randomized trial of 16 PACTs in primary care to compare the effectiveness of NCCP to usual care in
improving NAFLD care, with PACTs as unit of randomization and patients as the unit of analysis. The
multicomponent intervention includes an e-trigger to identify patients eligible for NAFLD screening and calculate
fibrosis scores, a structured provider education on NAFLD management and treatment recommendations, and
coordination by an interprofessional team. The primary outcome will be a composite binary variable consisting
of NAFLD diagnosis and risk stratification. Secondary outcomes include referral to a weight loss program, referral
of patients with advanced fibrosis to hepatology specialty care, and enrollment among those referred to weight
loss and hepatology specialty care. Summative evaluation will inform future implementation.
Next Steps/Implementation: Our study will provide information needed to support future projects to implement
the NCCP in VA primary care settings. The study will also lay the foundation for a subsequent project to examine
the adopted intervention’s effect on weight loss and NAFLD biomarkers in patients with high-risk NAFLD.

Public health relevance
Non-alcoholic fatty liver disease (NAFLD) is a new condition that has become the most common chronic liver disease in the world and a main cause of liver cirrhosis, liver failure and liver cancer . Obesity and diabetes, conditions that are very common among Veterans are the main risk factors for NAFLD. T herefore, the burden of NAFLD and its complications among Veterans is substantial. However, most VA patients with NAFLD are undiagnosed and untreated, and their care is not consistent with practice guidelines. Our NAFLD Clinical Care Pathway (NCCP) intervention seeks to close this major gap in the care of Veterans by automatically id entifying patients at risk of NAFLD, calculating their risk scores of having severe NAFLD, and educating the primary care providers on the diagnosis and treatment of NAFLD. This clinical trial will test the benefit of this NCCP intervention against usual care in increasing the rates of NAFLD diagnosis as well as referral to and enrollment in appropriate treatment. The study will also identify barriers and promotors of future NCCP implementation.